Developmental Funds

PROJECT SUMMARY/ABSTRACT
The Holden Comprehensive Cancer Center (HCCC) uses developmental funds to advance the research
mission of the HCCC based on the HCCC strategic plan and to address the needs of the HCCC catchment
area. This includes supporting promising research through seed grants, new faculty recruitments in areas of
high priority for HCCC research and support for a staff investigator. Developmental fund support for the P30 is
combined with institutional and philanthropic resources to achieve these goals.
Two classes of seed grants are awarded to support new cancer research ideas. These grants are named in
memory of prior HCCC investigators. Oberley Award recipients are selected by program leaders based on the
most promising, high risk research taking place within their programs. In some cases, program leaders have
chosen to work across programs to select Oberley Awards to support interprogrammatic collaborations that
address issues of high priority for the catchment area. Mezhir Awards are provided to support transdisciplinary
team science with a focus on new teams that have promise for larger P-award level funding.
Developmental funds are used to support recruitment of both senior and junior faculty. These recruitments
focus on areas where there is a particular need as outlined in the HCCC strategic plan, including for scientific
leadership within the HCCC.
Finally, developmental funds are used to support staff investigators who fill a unique role in the cancer center.
In the upcoming funding period, such funding is requested for Maria Spies, PhD who leads the HCCC DNA
repair group.

Public health relevance
PROJECT NARRATIVE Not applicable